Disparities in the management and prognosis of type 1 diabetes

Michael Fang, PHD, MHS is an Assistant Professor in the Department of Epidemiology at Johns Hopkins
Bloomberg School of Public Health. He seeks a K01 Mentored Research Scientist Development Award in
order to obtain essential skills and mentored research experience for an independent career as a scientist in
the field of diabetes epidemiology. The research proposal details a five-year plan to characterize the
epidemiology of type 1 diabetes in children and adults in the US. Using data from a large administrative claims
database, the specific aims of the research agenda are to: 1) Describe trends and racial, ethnic, and
socioeconomic disparities in the use of diabetes technologies; 2) Quantify changes in the attainment of
glycemic control and rates of morbidity and mortality, overall and across subgroups; and 3) Develop a new
simulation model of type 1 diabetes to characterize disparities in life expectancy and lifetime risk of
complications. Findings from the proposed research will identify the most pressing health problems
affecting persons with type 1 diabetes, identify critical gaps in care, and inform efforts to reduce health
inequities in the population. As part of his mentored career development, Dr. Fang will receive in-depth
training in risk prediction, simulation methods, and translational research under the mentorship of Dr.
Elizabeth Selvin, PhD, MPH, and Dr. Jung-Im Shin, MD, PhD. Dr. Fang’s immediate career goals include
developing expertise in analyzing “big” electronic health records data using a broad range of analytic
approaches, including risk prediction, simulation modeling, and health informatics methods; generating
rigorous evidence that can inform type 1 diabetes management and health policy; and fostering local, national,
and international collaborations with researchers in similar and complementary areas of research/expertise.
Long-term, Dr. Fang aims to establish a research program to characterize the global epidemiology of type 1
diabetes, with the goal of informing clinical recommendations and health policies for type 1 diabetes
management worldwide.

Public health relevance
Racial, ethnic, and socioeconomic disparities in type 1 diabetes management and outcomes are poorly defined. Using data from a large administrative claims database, this project will rigorously characterize inequities in the use of diabetes technology, the attainment of glycemic control, and the burden of major morbidity and mortality among children and adults with type 1 diabetes. These data will identify critical gaps in the management of type 1 diabetes and inform efforts to reduce social disparities in the population.